Optimizing Pain Treatment In Children On Mechanical ventilation (OPTICOM)

PROJECT SUMMARY/ABSTRACT
More than 24,000 children develop acute respiratory failure (ARF) and require invasive mechanical ventilation
(MV) – an intrusive, painful, yet lifesaving procedure – in the US each year. There is a critical knowledge gap
regarding the optimal approach for analgosedation (analgesia-based sedation) in these children. As a result,
the current standard-of-care is to provide opioids for the duration of MV. Despite high-dose opioid exposure,
more than 90% of these children have suboptimal pain control. Studies show that repeated episodes of acute
pain and prolonged opioid exposure put children at risk for chronic pain, opioid tolerance, withdrawal, delirium,
and other negative effects. Yet, few randomized controlled trials (RCTs) target optimizing acute pain
management in this high-risk population. In our study, Optimizing Pain Treatment In Children On
Mechanical ventilation (OPTICOM), the central hypothesis is that a protocolized strategy of administering
non-opioid adjuvant therapies to children with ARF will reduce pain and decrease opioid exposure. The primary
objective of OPTICOM is to define the effectiveness of supplementing opioids with acetaminophen and/or
ketorolac at decreasing episodes of acute pain in children with ARF on MV. This large-scale multi-site double-
blind placebo controlled RCT will enroll 644 children across 14 pediatric intensive care units (PICUs) and
randomize to one of 4 arms: Acetaminophen + Placebo; Ketorolac + Placebo; Acetaminophen + Ketorolac; or
Placebo + Placebo. We will systematically monitor all children for acute pain for the first 5 days of IMV and
quantify total opioid exposure in morphine milligram equivalents per kg as defined by the HEAL common data
elements. Effects of acetaminophen and ketorolac will be determined using a 2x2 factorial design. This
innovative proposal will leverage the extensive resources and experience of the Collaborative Pediatric Critical
Care Research Network (CPCCRN) at executing clinical trials in the complicated PICU environment to achieve
results within the 5-year study period. CPCCRN will ensure enrollment of a geographically, racially, and
socioeconomically diverse patient population to allow for wide generalizability of study findings. By expanding
HEAL-KIDS research into a unique and unstudied population, this project will lead to a paradigm shift in the
care provided to critically ill children. Consistent with the goals of the Acute Pain Clinical Trials Program, the
OPTICOM study will advance the treatment of acute pain in a diverse population of children across the age-
spectrum and advance our ultimate goal of developing comprehensive evidence-based clinical guidelines for
management of pain in children with ARF.

Public health relevance
PROJECT NARRATIVE Children with acute respiratory failure (ARF) require invasive mechanical ventilation (MV) – an intrusive, painful, lifesaving procedure. They universally receive high-dose opioids, yet still experience episodes of acute pain. Optimizing Pain Treatment In Children On Mechanical ventilation (OPTICOM) is a well-designed large-scale randomized controlled trial that will define the effectiveness of supplementing opioids with acetaminophen and/or ketorolac at (i) reducing pain and (ii) decreasing opioid exposure in this vulnerable population.